The Development and Evaluation of Visual Communication Tools to Convey Parental and Intergenerational Cardiovascular Disease Risk and Evoke Lifestyle Behavior Change in Low-income Black Families

PROJECT SUMMARY:
Despite decades of research and growing public awareness, obesity affects Black children from low-income
households disproportionately. This leads to disparities in obesity, cardiovascular disease, and several other
co-morbidities in adulthood. Parents play an important role in obesity and cardiovascular disease prevention by
shaping their child’s dietary and lifestyle behaviors early in life. However, Black parents from low-income
households face numerous socioeconomic barriers. Parents from these communities seek tangible and
practical lifestyle advice that can be implemented despite these barriers. While health care providers in the
primary care setting are often tasked with providing this advice and empowering parents to implement lifestyle
behavior change, they lack efficient, effective, culturally relevant, and engaging tools that can convey the
intergenerational risk of obesity and cardiovascular disease and facilitate changes in lifestyle behaviors for all
members of the family. My long term goal as an independent researcher is to improve child health outcomes
through a career focused on reducing disparities in obesity and its comorbidities by designing family-centered,
bio-behavioral interventions that evoke motivation to change, facilitate progression to actionable steps, and
augment the maintenance of behavior change in families from low-income households and minority racial
groups. The objective of this study is to develop, assess, and evaluate the acceptability, feasibility, and
preliminary efficacy of two visual communication tools, that make use of a visual image (graphical versus
illustrative) coupled with structured, culturally relevant, brief behavior change counseling, to convey CVD risk in
Black parents with obesity who have a school-age child (6-11 years) and are from a low-income household.
Specifically, this study aims to: (1) develop two visual communication tools via iterative focus groups with a)
Black parents affected by obesity and b) primary care health care providers (HCPs); (2) determine the
acceptability and feasibility of each visual communication tool during a simulated clinical encounter with Black
parents and HCPs; and (3) determine the preliminary efficacy of the two visual communication tools on
intention to change, perceived risk, knowledge of CVD risk, and short-term lifestyle behavior change in parents
affected obesity compared to a standardized CVD risk score. My career development plan includes
mentorship, formal coursework, and seminars in three focus areas: acquire skills in the development of visual
communication tools to convey disease risk in a culturally relevant way; gain expertise in the clinical application
of Motivational Interviewing through culturally relevant brief behavior change counseling; obtain competence in
designing randomized controlled trials in family-based behavior change interventions. Results from this study
will determine the most salient tool for this population which will be tested in a randomized controlled trial (R01)
to determine the effect on lifestyle change in parents and their children.

Public health relevance
PROJECT NARRATIVE: Black and low-income populations are disproportionately affected by obesity and its comorbidities, including cardiovascular disease. Although primary care health care providers could play an important role in providing tangible and practical lifestyle advice to prevent childhood obesity, they lack efficient and effective tools to engage parents and evoke change. This study will develop, assess, and evaluate the acceptability, feasibility, and preliminary efficacy of two visual communication tools that incorporate culturally relevant brief behavior change counseling grounded in motivational interviewing, to facilitate engagement in behavioral lifestyle counseling between primary care health care providers and Black parents from low-income households who are affected by obesity.